Diamond NMR spectrometer for microfluidic metabolite profiling

Project Summary. Nuclear magnetic resonance (NMR) is among the most powerful analytical techniques ever
invented, as recognized by 6 Nobel Prizes for methods development alone. Nonetheless, NMR is notoriously
plagued by poor sensitivity. State-of-the-art NMR spectrometers feature detection thresholds of ~5 nanomoles
for µL sample volumes (~100 nanograms). This places NMR sensitivity many orders of magnitude behind other
analytical chemistry techniques such as mass spectrometry, Raman spectroscopy, and fluorescence labeling.
Improvements in NMR often focus on using larger magnets, but progress has plateaued; over the last 30
years, the fundamental signal strength has only increased ~2-fold.
We seek to fundamentally change the NMR hardware by using diamond films doped with Nitrogen-Vacancy
centers to detect nuclear magnetization non-inductively via pulsed optically detected magnetic resonance
methods. The form factor of our NMR detector is easily integrated with hyphenation techniques so that
samples can be separated into sub-components before analysis. In Phase I, we improved the sensitivity of
diamond quantum sensors to the femtotesla level and identified microwave protocols suitable for high field
operation. We built a tabletop microfluidic diamond NMR apparatus with 40 pL detection volume and used it for
proof-of-principle NMR analytical chemistry experiments. In Phase II, we will optimize sensor spectral
resolution and sensitivity, miniaturize the setup into a benchtop device, and validate its operation using
metabolite mixtures. Afterwards, we will deliver our devices to end-users in industry (Merck) and academia
(UW) and incorporate feedback to scale up to market.
If successful, our prototype could have a profound impact on analytic biochemistry research, by combining
mass-spectrometry-level sensitivity with NMR-level accuracy. Specifically, we improve upon existing analytical
methods by offering:
1. Greater performance. We offer 1000-fold better sensitivity (picomole instead of nanomole) than current
NMR spectrometers. This sensitivity approaches that of mass spectrometry but retains benefits of NMR such
as non-destructive, absolute quantitation and structural identification.
2. Compatibility with hyphenated separation techniques. Our spectrometer is compact and easily
integrated into microfluidic chips with online high-performance liquid chromatography-based assays (HPLC) for
sample-limited analyses (metabolomics, pharmacodynamics, natural products).
3. Low cost. The small sample volume in our spectrometer leads to reduced engineering costs, resulting in
greater affordability compared to current high-end NMR spectrometers.

Public health relevance
ODMR Technologies, in collaboration with UNM, seeks to fundamentally change the hardware used in nuclear magnetic resonance spectroscopy by using laser and microwave interrogation of magneto-fluorescent diamonds embedded in a microfluidic chip. If successful, the diamond spectrometer will be used to quantify metabolic concentrations in unrefined samples for applications in analytical biochemistry and drug development.